Targeting TRAPPC11 as a therapeutic in inherited dilated cardiomyopathy

Project Summary
Dilated cardiomyopathy (DCM) is a common cause of heart failure with a severe lack of therapeutics,
creating a significant clinical burden. The gene TRAPPC11 emerged from a whole transcriptome, functional
screen for therapeutic targets for DCM using patient-derived human induced pluripotent stem cell-derived
cardiomyocytes (hiPSC-CMs), demonstrating reversion of contractile dysfunction upon knockdown in DCM
hiPSC-CMs. TRAPPC11 is a modulator of endoplasmic reticulum (ER) stress. Since ER stress is recognized as
a pathophysiological driver in DCM, my overarching hypothesis is that inhibition of TRAPPC11 would be
therapeutic for DCM caused by TNNT2 mutations and possibly more broadly for other forms of DCM. This
hypothesis will be tested through knockdown of TRAPPC11 in a mouse model of TNNT2 DCM and in myofilament
and nonmyofilament induced DCM in hiPSC-CMs. Interestingly, single nucleotide polymorphisms (SNPs) in
TRAPPC11 are associated with left ventricular hypertrophy (LVH) in response to pressure overload in African
Americans. Therefore, my secondary hypothesis is that common mechanisms underlie TRAPPC11’s effect on
hypertrophy induction and its therapeutic potential for DCM. Using CRISPR/Cas9 genome editing, I will test the
effects of TRAPPC11 SNPs associated with LVH on ER/SR function in healthy hiPSC-CMs and introduce key
SNPs into DCM hiPSC-CMs to assess their protective potential. Completion of this study will establish a
translational and mechanistic rationale for targeting TRAPPC11 in DCM, and might warrant monitoring clinical
outcomes of people carrying these SNPs for evidence supporting translatability of targeting TRAPPC11 to treat
DCM. The training program proposed in this fellowship application was created to support my potential to become
an independent investigator in the future. It will take place in the highly supportive, rich academic environment
of Stanford University, where I will have access to state-of-the-art facilities and the opportunity to interact with
leading cardiovascular researchers. The plan encompasses scientific technical skills, professional development
skills, and both written and oral communication skills and will prepare me for writing my career development
award.

Public health relevance
Project Narrative Dilated cardiomyopathy (DCM) is a common cause of heart failure with a severe lack of therapeutics, creating a significant clinical burden. TRAPPC11 encodes an integral trafficking protein whose knockdown rescues contractile dysfunction in DCM patient-derived human induced pluripotent stem cell-derived cardiomyocytes. This project explores the therapeutic efficacy of targeting TRAPPC11 knockdown in mice, various genetic DCM, and through loss of function single nucleotide polymorphisms to generate a translational and mechanistic rationale for targeting TRAPPC11 in DCM.